Flow Cytometry Human Immune Monitoring Shared Resource

ABSTRACT: FLOW CYTOMETRY AND HUMAN IMMUNE MONITORING SR (FCHIMSR)
The Flow Cytometry and Human Immune Monitoring Shared Resource (FCHIMSR) provides Sidney Kimmel
Cancer Center (SKCC) members with state-of-the-art fluorescence activated cell sorting and analysis
capabilities, as well as full service immune profiling for clinical and translational scientists. The SR was founded
as the Flow Cytometry Shared Resource (FCSR) in 1991 and has been continuously funded by the CCSG since
1996. Due to complementary expertise and services, the FCSR merged with the Clinical Cancer Immunology
Core (CCIC), a developing core performing ongoing assessments of immune function in patients enrolled in
clinical trials, in 2022 to become the FCHIMSR. The FCHIMSR maintains state-of-the-art instrumentation,
including Bioscience cytometers, Luminex FM3D, and Nanostring GeoMX spatial transcriptomic profiler and
provides expertise in high-parameter panel design, data analysis and interpretation, standardized protocols, and
technical support. Additionally, the FCHIMSR aids clinical researchers with sample collection, isolation, and
storage; cytokine, growth factor, and other soluble analyte profiling; and spatial transcriptomic analysis.
The FCHIMSR is led by Director Larry Harshyne, PhD, Associate Professor of Microbiology and Immunology.
Harshyne led the CCIC for four years and brings 25 years of experience in flow cytometry and immunology
expertise to the SR. Harshyne transitioned into the Director’s role upon the retirement of long-time Director Jianke
Zhang, PhD. FCHIMSR is centrally located within the headquarters for the SKCC, the Bluemle Life Sciences
Building (BLSB) at TJU, and is readily accessible to SKCC consortium members via a short walk (<1 mile). The
Specific Aims of the FCHIMSR are to: 1) Provide high-quality and affordably priced services for analysis and
sorting of cells, biological particles, and extracellular vesicles, 2) Provide end-to-end services for clinical
investigators wishing to perform immune assays, and 3) Provide education and training to SKCC members, staff,
and trainees. During the project period, the FCHIMSR served 114 SKCC members, 59 (51.8%) of which had
peer-reviewed funding, representing all four Research Programs. FCHIMSR services were utilized by 155 total
users in 117 peer reviewed publications (average impact factor 10.15), 41 grant applications, and 3 clinical trials.
In line with the SKCC strategic plan, IMPACT PHL, and under the guidance of the Director and advisory boards,
the FCHIMSR has set six goals for future development: 1) Upgrade bench-top analyzers to new multilaser
cytometry systems through NIH S10 grants and supplemental institutional funding, 2) Acquire 96-well plate
readers and automated sampling stations to increase high-throughput analysis, 3) Disseminate cytometry
protocols to standardize staining and strengthen analyses, 4) Expand educational offerings to include monthly
working groups and classroom lectures, 5) Seek out novel flow cytometric capabilities to monitor immune health
in clinical trial patients, and 6) Recruit a Co-Director to replace Jianke Zhang, PhD, who retires on June 1, 2023.